Inhibiting Adrenomedullin signaling to prevent mammalian brain endothelial cell abnormalities and brain arteriovenous malformation

Project Summary/Abstract
Like all mammalian vascular beds, the central nervous system relies on a functional vascular system (the
neurovascular system) to maintain the developmental and metabolic activities of its resident cells.
Neurovascular compromise thus imparts direct and indirect consequences to parenchymal tissue, and those
consequences impair central nervous system function. Brain arteriovenous malformation (AVM) is a human
neurovascular disease characterized by abnormal blood vessel morphology and organization – these
abnormalities lead to feed-forward changes in hemodynamics that increase the risk of hemorrhagic stroke,
chronic disability, and death. Currently, there are no Food & Drug Administration-approved pharmacological
treatments for brain AVM; thus, understanding the mechanistic underpinnings of this disease will inform on
molecular-based therapies.
Through the Funded Parent Project, we are using in vivo and in vitro approaches to examine whether
Adrenomedullin signaling is required for vascular abnormalities associated with Rbpj-deficient brain AVM in
mice and for cellular perturbations caused by RBPJ deficiency in cultured human brain endothelial cells. The
experimental aims in this Diversity Supplement will use our in vitro human brain endothelial cell system to
determine whether cytoskeleton dynamics are affected in RBPJ-deficient endothelial cells and whether small-
molecule inhibition of Adrenomedullin signaling can prevent cytoskeleton dysfunction.
We will test the hypothesis that inhibition of Adrenomedullin signaling, in the context of endothelial RBPJ-
deficiency, will normalize cytoskeletal organization and function, and thereby prevent those abnormalities from
promoting endothelial cell dysfunction. This hypothesis will be addressed in two supplemental aims that will
determine whether inhibition of Adrenomedullin signaling, via administration of the small-molecule inhibitor
NSC16311, prevents dysregulation of F-actin polymerization dynamics (Supplemental Aim 1) and prevents
dysregulation of F-actin turnover rate (Supplemental Aim 2) in cultured, RBPJ-deficient human brain
endothelial cells.
These studies will advance our long-term research objectives, which are to understand how loss of RBPJ leads
to brain endothelial cell dysfunction and how such dysfunction contributes to neurovascular pathologies like
brain AVM. Our work will also inform on the efficacy of pharmacological inhibition to normalize aberrant cell
signaling, to prevent endothelial cell dysfunction, and thereby to promote neurovascular health.

Public health relevance
Project Narrative Brain arteriovenous malformation (AVM) is a human neurovascular disorder in which perturbations to vascular cells – including endothelial cells that line the inner lumen of blood vessels – can trigger debilitating blood vessel dysfunction. We previously reported abnormal brain endothelial cell shape, directionality, and movement, using in vitro and in vivo models of endothelial cell dysfunction and brain AVM. We will test the hypothesis that abnormalities to the cytoskeleton underlie brain AVM-related endothelial cell dysfunction and that pharmacological-based normalization of endothelial cell signaling will prevent cytoskeletal anomalies and restore cellular function.